STUDY OF GALLIUM NITRATE FOR THE TREATMENT OF MALIGNANT DISORDERS

The purpose of this investigation is to evaluate the safety and side effects of gallium nitrate when used as an anti-cancer agent and to evaluate the side effects in children.